Project 1 - Cardiometabolic Injury due to VOCs

PROJECT SUMMARY
The overall goal of this project is to assess the impact of exposure to Superfund-relevant volatile
organic compounds (VOCs) on cardiometabolic disease, the underlying conditions that
contributes to diabetes, cardiovascular and liver diseases. VOCs such as trichloroethylene,
benzene, acrolein, formaldehyde, xylene and butadiene are major chemicals of concern at most
Superfund sites and extensive previous work suggests the exposure to VOC could have a variety
of adverse health effects. Nevertheless, whether exposure to VOCs at levels relevant to
neighborhood adjacent to Superfund sites could adversely affect cardiometabolic health remains
unknown. Our extensive studies with animal exposed to different VOCs suggest that chronic
exposure to low dose VOCs could increase blood pressure, inflict vascular injury, accelerate
atherosclerosis, and induce liver disease. Nevertheless, the cardiometabolic risk of VOCs has
not been evaluated and longitudinal data to interrogate exposure-response relationships are
missing. Hence, to assess CMD risk imposed by VOCs, we will test the hypothesis that exposure
to VOCs exacerbates/induces vascular and hepatic dysfunction leading to a cascade of events
that increase CMD risk. To assess the impact of VOC exposures, we will examine 1200 residents
of Jefferson County, including those who live in areas adjacent to Superfund sites such as Lee’s
Lane and Distiller Farm, as well as high VOC emission, such as the Rubbertown neighborhood.
In each participant, we will assess CMD risk by measuring arterial stiffness, marker of hepatocyte
death, as well as suite of biomarkers indicative of risk for diabetes, cardiovascular and liver
diseases. To determine population-level VOC exposure and its relationship with CMD-related
hospital admissions and mortality, we will establish a network of VOC monitors to measure VOC
levels throughout Jefferson County and monitor domestic wastewater for urinary VOC
metabolites. We will monitor wastewater every other month for 3 years, and assess the extent to
which population-level exposure estimates reflect ambient air VOC levels and individual-level
exposure (Aim 1), and how these estimates relate to population-level and individual-level CMD
risk. To obtain longitudinal data, we will examine CMD progression and determine the
association between individual-level and community-level VOC exposures with vascular and
hepatic function and other indices of cardiometabolic risk. This will help us in assessing how VOC
exposure and/or residential proximity to Superfund sites affects the risk of CMD and this
excessive risk differs from that imposed by background VOC exposures in urban neighborhood.
We expect that completion of this project will lead to the development of quantitative risk models
and rigorous estimates of the additional CMD risk attributable to residential VOC exposures.

Public health relevance
NARRATIVE This project is to identify, assess, and evaluate the potential health effects due to exposure to hazardous chemicals prevalent in urban neighborhoods and areas around Superfund sites.